Comprehensive Cancer Center Program at Fox Chase

PROJECT SUMMARY/ABSTRACT – OVERALL
The Fox Chase Cancer Center (FCCC), now in its 51st year as an NCI-designated Comprehensive Cancer
Center, has undergone a profound transformation since the time of the last CCSG grant review. In 2012, Fox
Chase entered into an affiliation with the Temple University Health System, creating a unique new model that
combines the flexibility of a free-standing cancer center with the scientific and clinical breadth of a university-
based matrix center. In addition to this organizational change, in 2013, FCCC came under new leadership with
the appointment of Richard I. Fisher, MD as President and CEO of FCCC and Cancer Center Director. As a
result of these developments, the size and scope of the Cancer Center have greatly expanded, both in terms of
its scientific enterprise and also in the number and diversity of the patients served. Cancer-focused, Temple
faculty members have been thoroughly integrated into FCCC, adding 54 new CCSG members, including three
in leadership positions (Jean-Pierre Issa, MD, PhD, Co-Program Leader for Cancer Epigenetics; Susan
Fisher, PhD, Associate Director for Population Science; Grace Ma, PhD, Director of Community Based
Research). In addition to expanding membership, the affiliation has enabled access to specialized expertise at
Temple University, including the Fels Institute for Cancer Research and Molecular Biology, the Moulder Center
for Drug Discovery, and the newly created School of Public Health. Importantly, with the affiliation, FCCC now
has greatly enhanced access to an underserved population within its catchment area, surrounding the Temple
University Health Science Center in North Philadelphia. Other important accomplishments within the last grant
cycle include: a) Recruitment of Wafik El-Deiry, MD, PhD to a new Deputy Directorship for Translational
Research to enhance the clinical translation of basic research findings; b) A 40% increase in the direct costs of
funded research at FCCC from 2013 - 2015 ($27.7M to $38.7M); c) 43-fold return on investment from CCSG-
supported pilot projects; d) Increased accrual to treatment interventional trials, from 358 in 2011 to 668 in 2014
(an 87% increase); e) Establishment of a cutting-edge Research Program in Cancer Epigenetics; and f)
Publication of more than 2,200 papers from 2011-2015, with strong intra- and inter-programmatic collaboration,
including 20% in journals with Impact Factors > 8, and 11% in journals with Impact Factors > 10. These
positive developments demonstrate the renewed strength of FCCC and the importance of its role in the care of
cancer patients in this region.

Public health relevance
PROJECT NARRATIVE – OVERALL NCI-designated Cancer Centers such as Fox Chase Cancer Center serve as major sources of discovery of the nature of cancer, and development of more effective approaches to prevention, diagnosis and therapy.